Targeting stage specific influxed monocytes to treat acute and chronic back pain

Targeting stage specific influxed monocytes to treat acute and chronic back pain
Back pain is the most common contributor to lost workdays, with intervertebral disc herniation being a
leading contributor. The pathogenesis of disc herniation and associated pain involves complex immune
responses in which monocytes play key roles. Monocyte-specific C-C motif chemokine receptor 2 (CCR2) is
critical for their recruitment to inflammatory tissues. Using transgenic mice for monocyte fate mapping, we
detected a continuous influx of monocytes at disc hernia sites. Early CCR2 antagonist treatments markedly
reduced total monocytes and macrophages at these sites and attenuated acute pain, whereas later treatments
reduced subsequent monocytic influx with little impact on already infiltrated macrophages. However, it remains
unclear how infiltrated monocytes respond to the local microenvironment and contribute to either the recovery
or deterioration of disc herniation and associated pain. We hypothesize that blocking early infiltrating monocytes
may alleviate acute inflammation but may lead to chronic inflammation due to inadequate initial inflammatory
response and residual disc tissue. In contrast, inhibiting late-infiltrating monocytes mitigates chronic inflammation
and augments the tissue repair function of early infiltrated monocytes-derived macrophages in disc herniation.
The goal of this study is to determine the fates and functions of CCR2 monocytes in response to the specific
microenvironment at the hernia site, aligning with our long-term goal to identify disease-modifying therapies. We
will use a highly innovative inducible transgenic mouse strain to trace monocytes at various stages (Aim 1). We
will distinguish the roles of the early and late influxes of monocytes by administering a clinically tested CCR2
antagonist (Aim 2). Additionally, we will elucidate and validate differences in human specimens taken at acute
and chronic stages and establish correlations between signature effectors and clinical manifestations (Aim 3).
Understanding of the immune responses at the molecular level will improve long-term outcomes by identifying
biomarkers and target therapies.

Public health relevance
Project Narrative The proposed research is highly relevant to public health as it explores the functions of monocytes in the progression of intervertebral disc herniation and associated back/leg pain. Understanding these mechanisms is fundamental for developing effective treatments and preventing the transition from acute to chronic inflammation and persistent pain. This research aligns with the mission of the NIGMS by enhancing our understanding disease progression of disc herniation related back pain and laying the foundation for advances in treatment.